Type 5 secretion as a novel mechanism to deliver protein effectors directly into mammalian host cells

Project summary
All host-adapted Bordetella species encode large filamentous hemagglutinin-like adhesins termed FhaL.
Global expression studies indicate that fhaL is a virulence-activated gene, and FhaL peptides are detected in
the secretome of B. pertussis cells cultured under pathogenic growth conditions. Although the FhaL expression
profile suggests a function during host colonization, the activity of this putative adhesin has not been examined
experimentally. We find that FhaL has a remarkably similar domain architecture as antibacterial CdiA effector
proteins, which deliver C-terminal toxin domains into neighboring bacteria to inhibit target-cell growth. We
propose the FhaL uses a similar delivery mechanism to translocate putative effector domains into eukaryotic
host cells. FhaL carries four cargo modules, each composed of C80 cysteine peptidase and putative effector
domains. The peptidase domains are homologous to auto-proteolytic domains found in MARTX toxins,
suggesting that FhaL releases it effector domains through auto-processing after translocation into the host cell
cytosol. FhaL effector domains share between 25% and 45% pair-wise identity with each other, but are not
homologous to any other protein of known function. AlphaFold2 modeling indicates that the effector domains
adopt similar folds with distant structural homology to esterases and hydrolases. This project will determine
whether FhaL acts as a contact-dependent effector delivery system and test whether the effector domains act
as toxic hydrolases to disrupt host cell physiology.

Public health relevance
Narrative This proposal focuses on the uncharacterized FhaL adhesin of Bordetella bacterial pathogens, which cause a variety of respiratory infections in humans, rodents and fowl. We hypothesize that FhaL delivers a collection of effector domains into eukaryotic host cells. This work promises to establish a new role for type 5 secretion systems in virulence and will significantly increase our understanding of Bordetella pathogenesis.